The impact of reduction of cellular senescence on age-related epigenetic heterogeneity

PROJECT SUMMARY
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
23-045. The decline in hematopoietic stem and progenitor cell (HSPC) function with aging can lead to improper
blood and immune cell production, contributing to reduced health and life span. Aged HSPCs accumulate
somatic mutations that confer a selective fitness advantage, leading to clonal hematopoiesis (CH), a blood
phenotype that increases the risk of leukemia and various diseases of aging including cardiovascular diseases.
Cellular senescence, a hallmark of aging, is another potent extrinsic candidate driver for age-related CH in the
bone marrow microenvironment. Senescent cells secrete inflammatory factors that can influence the function
and differentiation of surrounding cells, including cytokines that are crucial for driving CH. Determining the impact
of reducing cellular senescence on the epigenetic heterogeneity of HSPC in aged bone marrow of mice is
significant for aging and cancer research, given that greater epigenetic heterogeneity of HSPC with age should
alter both stem cell functionality in hematopoiesis and increase the odds of leukemic progression. We will test
the hypothesis that rejuvenating the bone marrow microenvironment by reducing senescence will reduce
epigenetic heterogeneity of HSPC. This knowledge can contribute to the development of novel therapeutic and
preventative strategies for mitigating age-related blood disorders, ultimately benefiting prevention of both
hematopoietic decline and increased blood malignancy risk in the elderly. To follow the fate of specific subclones
of HSCs, we will uniquely barcode thousands of HSC from old wildtype mice, which will be transplanted into
three groups of host mice with vehicle or senolytic treatment to determine how aged vs. rejuvenated BM
microenvironment influences HSPC heterogeneity. We will use scRNA-seq and snATAC-seq analysis to identify
cell cluster-associated epigenetic and transcriptomic signatures and associated heterogeneity for expanded vs.
contracted HSC clones. We will also identify senescence-dependent epigenetic signatures and associated
heterogeneity from post-transplantation snATAC-seq data. The expected outcomes of this research will be to
determine the impact of cellular senescence reduction on the epigenetic heterogeneity of HSPC in aged bone
marrow of mice and identify the specific pathways that are modulated given the rejuvenated, less inflammatory
microenvironment. This work can provide a mechanistic foundation for understanding the initiation of age-related
blood disorders.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia (AML) is a deadly blood cancer that occurs mostly in adults over 65 and is associated with the abnormal overproliferation of blood stem cells, a common age-related condition called 'clonal hematopoiesis' (CH). Although we know that aging and specific gene mutations in the blood stem cells contribute to the development of CH and its progression to AML, we do not understand how old age and CH interact to promote the evolution of AML. Here, we will elucidate how aging and CH influence the propensity of blood stem cells to adapt to altered environments (“evolvability”), which could not only forge a new paradigm for our understanding of leukemia onset but also provide candidate pathways for the development of preventative interventions.